Biostatistics and Informatics Core

PROJECT SUMMARY/ABSTRACT
The Biostatistics and Informatics Core is a newly formed Core to support the central aims of the University of
Washington (UW) Cystic Fibrosis (CF) Research and Translation Center (CFRTC). It is formed under a
continuity of leadership and out of services that have been a cornerstone of the CFRTC by providing novel
design, analytics and quantitative methods and analytics. With the advent of big data in CF, a new
bioinformatics component has been added to the Core focused on applying cutting-edge computational
methods to analyze “omics” data. The Core leaders bring services, expertise, and a long history of
collaboration with CF researchers, especially in diabetes, pancreatic function and highly effect CF
transmembrane conductance regulator (CFTR) modulator therapy. Further, the Core has a strong training
component for CF researchers and clinicians. The Core establishment is an acknowledgement of the
increasing complexity of translational and basic research in CF and the need for a dedicated resource to
provide integrated analytic support to the UW CFRTC research base. The services focus on biostatistical
support, study design, epidemiologic methods, comparative effectiveness and cost analyses, ancillary study
enrichment, and novel bioinformatics services to guide and assist the research base with analysis of large-
scale omics data. The Core aims are consistent with the overall CFRTC: 1) adapt biostatistical methods and
outcomes to the post-HEMT era, 2) enhance understanding of non-pulmonary comorbidities in CF and improve
decision making and policy through effectiveness and cost analytics, 3) and perform state-of-the art
bioinformatics on human and animal data to understand pathophysiology and clinical manifestations of CF
post-HEMT. The Core will foster collaboration across the CFRTC through training and sharing existing
databases that enable ancillary analyses.